Protein Kinase A in Focal Adhesions - Mechanisms and Consequences

PROJECT SUMMARY
Cell interaction with the surrounding extracellular matrix (ECM) controls nearly every major cellular function
– including growth, division, survival, shape, and movement. The ECM is connected, vicariously, to the
intracellular actin cytoskeleton at focal adhesions (FAs) – multi-protein complexes that assemble and
disassemble to dynamically couple actin microfilaments to the cytoplasmic tails of matrix-bound integrins. In
addition to their coupling function, FAs also send & receive signals that communicate & control the adhesive
state of the cell. Prominent among these signals is reversible protein phosphorylation, with proteins containing
and controlling phosphotyrosine being particularly abundant, important, and well-studied in FA biology. This
importance notwithstanding, phosphoserine and phosphothreonine modification of FA proteins is far more
abundant than phosphotyrosine, but far less studied and understood.
Protein Kinase A (PKA) is a ubiquitous and promiscuous Ser/Thr kinase with complex regulatory roles in cell
migration. Several observations suggest that PKA may also be important for signaling within FAs. First, inhibition
of PKA early during cell attachment alters FA dynamics, increasing FA size and clustering, and decreases cell
spreading. Furthermore, PKA subunits as well as a number of putative PKA substrates have been identified in
isolated adhesion complexes as well as in published integrin- and/or focal adhesion-associated proteomes.
Furthermore, PKA subunits as well as a number of established and putative PKA substrates have been identified
in isolated adhesion complexes and in published integrin- and/or focal adhesion-associated proteomes. Using a
focal adhesion-targeted PKA biosensor, we have recently shown highly localized and dynamic PKA activity within
individual focal adhesions. Finally, using proximity-labelling and complimentary biochemical approaches, we
have shown that PKA regulatory (R) subunits closely interact with the archetypal focal adhesion protein talin. We
also report that PKA phosphorylates talin as well as the talin-associated proteins (TAPs) RIAM, DLC1, and TES.
Based on these observations, we hypothesize that a discrete pool of PKA interacts with talin, modifies talin and
TAPs, and enhances FA dynamics.
In summary, PKA associates with talin, but the biochemical nature and determinants of this interaction are
not known – this is the goal of Specific Aim 1. PKA appears to directly phosphorylate talin, but the sites and
effects of this modification are not known - this is goal of Specific Aim 2. PKA appears to directly phosphorylate
several talin-associated proteins, but the sites and effects of these modifications are not known – this is the
goal of Specific Aim 3. Finally, while talin and TAPs appear to represent an important target cluster for PKA,
the consequences of regulating this cluster on cell adhesion, FA dynamics, cell spreading and migration are not
known – this is the goal of Specific Aim 4.

Public health relevance
PROJECT NARRATIVE Just as a person’s behavior can be influenced by their surroundings, so too can the functions of individual cells be influenced by the cell’s microenvironment. When cells attach to & ‘sample’ this environment – called the extracellular matrix – they form specialized structures called focal adhesions that not only help the cells attach but also report and control the status of that attachment. This project focuses on a powerful ‘reporting’ or signaling protein, called Protein Kinase A (PKA, for short), that we have recently found is active within focal adhesions. We propose to investigate what keeps it there, what it’s controlling, and what it’s reporting – all with the hope that by learning more about this particular reporter, we will learn more about how cells are influenced by their surroundings.